Scientific Resource Core

Scientific Resource Core
The primary goal of the UNC Alcohol Research Center (ARC) is to increase understanding of molecular and
cellular pathogenesis in alcohol use disorder. The purpose of the Scientific Resource Core (SRC) is to facilitate
and extend this integrated research effort by providing access to cutting-edge technology, shared facilities,
resources and technical expertise. In addition, the SRC fosters interaction among ARC investigators with the
explicit purpose of increasing coordination and cohesiveness among individual Research Components. In this
renewal application, the SRC has three specific goals. First, the SRC will support functional connectivity
magnetic resonance imaging (fcMRI) combined with magnetic resonance spectroscopy (MRS) studies designed
to discover novel alcohol-induced changes in neural circuit connectivity and activity. This work will be conducted
in an expert-driven environment within the SRC using shared facilities within the UNC Biomedical Research
Imaging Center (BRIC). The SRC also provides equipment for conducting multi-channel fiber photometry to
measure Ca2+ signals in genetically encoded excitatory and inhibitory neurons in specific rodent brain regions.
Access to cutting-edge imaging technologies and high-end instrumentation significantly enhances the
capabilities of Research Components by providing rigorous methods, sophisticated facilities, user support, and
quality control of imaging. Second, the SRC provides facilities, resources, and expertise to allow measurement
of alcohol-induced changes in gene and protein expression and neural circuit function including optogenetics
and electrophysiology. These centralized facilities allow rigorous, standardized, and quality-controlled data
collection across a variety of models, and extend the capability of Research Components to include novel
methods. To assure effective functioning of the Core and to facilitate the integrative efforts of the ARC, the SRC
holds a monthly meeting of ARC investigators that evaluates progress and provides a venue for data and idea
sharing. Access to these resources and integrative environment is a highly significant feature of the ARC that
contributes to the accomplishment of our shared goals. Together, these services and resources provide the
Research Components with the unique capability of delineating alcohol-induced molecular changes in specific
brain regions that are associated with altered neural circuit connectivity. This synergistic effort will provide novel
insight into mechanisms of maladaptive changes in neural circuitry that underlie alcohol addiction. Moreover,
this innovative and integrative strategy represents a clear advantage to conducting the proposed research as
Center rather than separate research efforts.